EFFECT OF RECURRENT HYPOGLYCEMIA ON AUTONOMIC NERVOUS SYSTEM FUNCTION

The purpose of this study is to investigate how how blood sugar levels affect the activity of the autonomic nervous system in healthy individuals.